Understanding Resistance to Next Generation Antiandrogens

PROJECT SUMMARY/ABSTRACT
This R01 competitive renewal application focuses on a novel mechanism of acquired resistance to hormone
therapy in castration resistant prostate cancer (CRPC) called lineage plasticity. During the initial 5 year
funding cycle, we focused primarily on two other mechanisms of resistance: mutation or amplification of the
androgen receptor (AR) and bypass of AR signaling through upregulation of the closely related glucocorticoid
receptor. This work is described briefly in the Progress Report section of the Research Strategy and in the
papers cited in the Progress Report Publication List. Here we shift our attention to a third mechanism of
acquired resistance that we recently reported called lineage plasticity, in which prostate cancers escape
hormone therapy by changing their identity from an AR dependent luminal lineage phenotype to an AR
independent non-luminal lineage. This resistance mechanism occurs primarily in tumors deficient in the tumor
suppressor genes TP53 and RB1 (which account for ~15% of CRPC) and is explained, in part, by upregulation
of the reprogramming factor SOX2 which enables luminal epithelial cells to acquire characteristics of basal
epithelial, mesenchymal and neuroendocrine cells that are no longer dependent on AR signaling for survival.
We have developed genetically-defined mouse and human prostate cancer models (using organoid
technology, xenografts and orthotopic tumor models) that recapitulate all the phenotypes of lineage plasticity
observed in CRPC patients with reproducible, defined kinetics that make these models suitable for detailed
mechanistic investigation. In Aim 1, we will identify the regulators of these lineage transitions, starting with a
series of timecourse experiments using RNA-seq, ATAC-seq, chromatin ChIP-seq and single cell RNA-seq to
define the transcriptomic and chromatin landscape changes associated with these changing phenotypes. Aim
2 will address the mechanism by which antiandrogen therapy can accelerate the development of lineage
plasticity, which we postulate is through disruption of an AR-driven transcriptional program that helps maintain
luminal identity. The results could have implications for the timing and context in which hormone therapy is
used clinically. In Aim 3, we will identify candidate drug targets that block the development of lineage plasticity
by conducting a pooled CRISPR screen of a library focused exclusively on chromatin modifying enzymes
(selected based on our recent data implicating EZH2 as one such target). We will characterize the hits from
this screen with the long range goal of developing combination therapy regimens (with antiandrogen therapy)
that prevent resistance. In summary, this application will generate novel mechanistic insight into lineage
plasticity in prostate cancer, with obvious implications for the clinical challenge of drug resistance. The findings
are also likely to have relevance for other epithelial tumor types such as lung cancer, breast cancer and
melanoma where evidence implicating lineage plasticity as a cause of drug resistance has also emerged.

Public health relevance
PROJECT NARRATIVE 26,000 men die each year in the US from metastatic prostate cancer because the disease develops resistance to the primary treatment, called hormone therapy. DNA sequencing studies have identified a subset of patients who develop resistance through a mechanism called lineage plasticity, where the tumors change their identity from a luminal prostate cell that responds to hormone therapy to a non-luminal cell that is resistant. This application will investigate the molecular details of how this happens, using laboratory models and patient samples, with the goal of gaining insight into how to prevent this form of resistance from developing.